IL-27 is a protective cytokine during congenital infection

Cytokines govern key cellular processes of pregnancy with both pro- and anti-inflammatory activities. To prevent
immune dysregulation at the maternal-fetal interface, cytokines are thought to dictate these seemingly
contradictory immune responses through meticulous immune regulation. Yet, there is a gap in knowledge
regarding the mechanistic roles of many cytokines in the context of pregnancy, including the versatile cytokine
Interleukin 27 (IL-27). Our proposal will address this gap in knowledge, as we have recently established that the
IL-27 signaling circuit is active at the maternal-fetal interface and discovered that IL-27 is a protective cytokine
during congenital infection. IL-27 serves as a potent regulatory of inflammation, where it can be pro- or anti-
inflammatory dependent upon cellular context. Although initially recognized for its proinflammatory activities in
promoting immunity, IL-27 was later acknowledged for its profound ability to serve as an anti-inflammatory
cytokine during various infections where IL-27 has been found to act on various T subsets cells to limit
inflammation during infection. Moreover, IL-27 can directly influence viral infection through induction of antiviral
genes in IL-27 responsive cells. Based on literature and our extensive preliminary data, we hypothesize that IL-
27 is both an immunoregulatory and antiviral cytokine during pregnancy. This proposal describes targeted
objectives to define the mechanistic features of IL-27 signaling at the maternal-fetal interface that underlie its
protective capacity during congenital infection. In Aim 1 we will focus our investigations on defining the immune
regulatory functions of IL-27 at the maternal-fetal interface. We will uncover the cellular targets and impacts of
IL-27 signaling in dictating activation state of localized T cells. In Aim 2 we will focus our studies on the antiviral
functions of IL-27 in the placenta. We will evaluate the transcriptional dynamics of IL-27 signaling and antiviral
capacity of IL-27 signaling in mouse and human placental trophoblast organoids. Altogether, outcomes from this
proposal will embody new fundamental insights into regulatory cytokine communication at the maternal-fetal
interface. Specifically, this proposal will define the mechanisms underlying IL-27 protective immunity during
congenital infection, which could ultimately be leveraged to improve maternal and neonatal outcomes.

Public health relevance
Cytokines govern key cellular processes of pregnancy. We recently discovered that the cytokine Interleukin 27 (IL-27) is a critical player of immunity at the maternal-fetal interface, and here, we propose to define the mechanistic features of IL-27 signaling that underlie its protective capacity during congenital infection. Outcomes from our work will provide new fundamental insights into immune regulatory cytokine communication and function at the maternal-fetal interface with an overarching goal to improve neonatal outcomes.